Cancer Center Survivorship Research Forum

ABSTRACT
The goal of this proposed biennial survivorship symposium series is to improve cancer outcomes by creating a
regular forum for researchers, clinicians, and survivors to share cutting-edge research and foster new
collaborations, research, programs, and policies. One of the defining features of cancer survivorship care — at
the same time a strength and a challenge — is its multidimensional nature. The needs of cancer survivors are
complex, spanning both oncologic and other physical concerns (e.g., cardiovascular treatment sequelae),
psychosocial concerns, and practical concerns (e.g., financial burdenfrom medical expenses that affect the
whole family). Addressing these concerns and focusing on the best ways to deliver cancer survivorship care
requires close and careful collaboration between experts from multiple fields. The discontinuation of the
Biennial Cancer Survivorship Research conferences in 2016 left a gap in cancer survivorship care. The
proposed biennial symposium will fill this gap by facilitating knowledge exchange and sustained collaborations
and networking among researchers and clinicians from multiple disciplines, with additional input from patient
perspectives, and by identifying and formulating future directions of survivorship research with a focus on
equitable healthcare delivery. The first conference, held virtually during the COVID-19 pandemic, was hosted by
the University of Minnesota in April 2021 and was well attended. The second conference is planned for
September of 2023 at Stanford University. With the title of “Implementing Equitable Survivorship Care Across
the Life Span”, we aim to bring pertinent and cutting-edge research topics in the field of cancer survivorship to
a global community of diverse stakeholders. Topics will include the circle of survivorship care in
standardization, risk stratification, and implementation; implementing precision risk-stratified survivorship care;
priorities for survivorship research: global solutions to common challenges; and translating innovation into
clinical practice with a focus on diverse patient populations across academic and community practices.
Conference Plan

Public health relevance
PROJECT NARRATIVE In the past 10 years, cancer survivorship has matured into its own cancer discipline addressing the complex and changing needs of the growing population of cancer survivors, which now exceeds 18 million individuals in the United States. Cancer survivorship care requires innovative collaboration among experts from multiple healthcare disciplines who do not traditionally work together or attend the same conferences. This proposed biennial cancer survivorship symposium will fill a gap by creating opportunities for researchers and clinicians from multiple disciplines to share knowledge and successful clinical practices, network with each other, build sustained collaborations, and shape future directions of cancer survivorship research and care delivery.